HSR&D Senior Research Career Scientist Award

This renewal of a Senior Research Career Scientist (SRCS) award is to support Dr. Hayden Bosworth
to further provide scientific, mentoring and service contributions to Veterans. Dr. Bosworth’s main research
interests comprise 3 overarching areas that align with VA HSR&D and the VA secretary’s top priorities: 1)
Greater Choice for Veterans - build a high performing integrated network of care; 2) Improve Timeliness of
Services – improve access to care; and 3) Focus Resources More Efficiently – strengthen foundational
services in VA (e.g. primary care). He provides knowledge for improving patients' c h r o n i c c a r e self-
management; translate research to improve the quality of health care, and eliminate health care disparities.
The goal of this research is to develop and evaluate programs and delivery models that can be implemented in
the national VA health care system to improve the quality, efficiency and patient centeredness of care.
Dr. Bosworth has led over 30 federally funded (VA HSR&D, QUERI, NIH), foundation (e.g., American
Heart Association) projects and participated in another 60 as a co-investigator. Most recently, he has focused
on health care delivery including collaborations with the Office of Rural Health (ORH) and Connected Care. He
currently is the (co-)principal investigator on 3 Investigator Initiated Research (IIR) grants, 2 ORH funded
projects, and 2 industry-funded projects enrolling and serving VA patients (total 7). He is also the co-
investigator on three VA-funded IIR studies, the PI of a U01 and a K12 training grant, both awarded by NHLBI.
The latter provides resources to train 5 faculty for 3 years in implementation science. Since 2013, Dr. Bosworth
has published over 150 peer reviewed articles with more than half with current and formal mentees (total peer
reviewed publications 350 and 4 books); his Google Scholar h-index is 73 and his articles have been cited
more 19k times. Dr. Bosworth received the 2013 VA Undersecretary Award for Outstanding Achievement in
Health Services Research. The annual award is the highest honor for VA health services researchers.
In terms of mentoring, Dr. Bosworth is currently the primary mentor for 2 funded CDAs and is a
secondary mentor on 8 other career development awards (1 HSR&D, 1 RR&D, and 2 NIH K12, 2 K08, KL2
and one foundation training grant). As the PI of a K12 training grant, he is responsible for training of 5 MD/PhD
junior faculty. He is also senior mentor on the Durham-based VA Quality Scholars program. In his role as Vice
Chair, he is responsible for the development of a master’s and doctoral program in the Department of
Population Health Sciences. The courses required for these curricula incorporate qualitative methods, clinical
trials, health services research, and implementation sciences. Many of these courses are taught by and
accessible to VA faculty. He also has contributed to many national/international committees and leadership
panels. Recent activities include participating as a member/chair of HSR&D SREB study sections HSR 7 -
Aging and Diminished Capacity in the Context of Aging, leading a Durham COIN Virtual Care focus area. He
is also a Deputy Editor for Patient Education and Counseling and co-led a VA State of the Art (SOTA)
supplement on care coordination.
Dr. Bosworth’s proposed activities for the award period include: 1) leading a broad effort to understand
ways to adapt, scale, spread, and sustain population level interventions for Veterans with comorbid conditions
(e.g., as recent IIR HIV/cardiovascular disease submission and ORH project), 2) facilitate the adoption and
evaluation of models of virtual care including care coordination and the Mission Act legislation, and 3) mentor
junior investigators with interests in care models and implementation. The protected time allowed by a VA
HSR&D SRCS award will allow Dr. Bosworth to enhance his contributions to the VA HSR&D mission, with a
focus on enhancing quality, access and spread of successful healthcare delivery models. He will also continue
to mentor many junior faculty members and serve on the Charleston COIN executive committee.

Public health relevance
The goal of my research is to develop and test healthcare delivery models in the VA health care system to improve the delivery of quality, efficient, and patient-centered care. I have led > 30 federally funded (HSR&D, QUERI) and foundation projects. I am collaborating with the Offices of Rural Health (ORH) and Connected Care. Additionally, I am the PI/Co-PI of 3 IIRs, 2 ORH funded projects, and 2 industry-funded projects occurring in the VA. I am the PI of a U01 and a K12 training grant both from NHLBI. Since 2013, I published >160 papers. More than half of these were coauthored with VA mentees. I am the primary mentor for 2 CDAs, secondary mentor on 6 other CDA/K awards. Proposed activities include: 1) develop methods for scaling and adapting interventions for veterans with comorbid conditions, 2) facilitate the evaluation of models of virtual care as they pertain to the Mission Act legislation, and 3) mentorship. The Senior RCS award will allow me to enhance my contributions to the VA HSR&D mission and improve care for Veterans with chronic conditions.